RED KARD: Reducing Disparities in Knee Arthroscopy for Adolescents

The purpose of this K23 proposal is to facilitate Dr. Neeraj Patel’s development into an independent surgeon scientist who will generate patient- and stakeholder-centered input as well as design and implement interventions to reduce delayed care in pediatric sports medicine. Hundreds of thousands of youth athletes require surgery for knee injuries annually. The incidence of operative knee injuries has skyrocketed, but surgery can be delayed due to late recognition and factors such as insurance, language, and difficulty navigating the healthcare system. Delays may have lifelong effects, including arthritis, persistent instability, poor patient reported outcomes, and reoperation. There is little patient-centered research on difficulties obtaining orthopaedic care, and none on interventions to address them in pediatric sports medicine. To accomplish his long-term goals, Dr. Patel requires training in community engaged research (CEnR), qualitative methods, and implementation science. He will achieve these training goals through a comprehensive career development plan that includes strong mentoring, focused didactics, growing collaborations, and experiential training. This will guide him towards national expertise in disciplines where few orthopaedic surgeons have any background. His primary mentor is Dr. Rinad Beidas, an international leader in implementation science with extensive record of federally funded community research and mentorship. The mentoring team also includes a multidisciplinary group of researchers with complementary expertise: Drs. Namratha Kandula (CEnR and intervention design), Matthew Davis (pediatric CEnR and population health research), and Julie Johnson (qualitative methods). Dr. Patel’s development will be bolstered by the robust resources of Lurie Children’s Hospital and Northwestern University. The proposed study will focus on children who are at increased risk of delayed knee surgery. The overall objectives are to identify factors affecting timely knee surgery in high school athletes and develop an intervention to implement evidence on expedient treatment. The specific aims are to:
(1) identify factors preventing or facilitating timely care of knee injuries for high school athletes; (2) design an evidence-based intervention for athletes, families, and coaches to reduce delays in evaluation of acute knee injuries via user-centered principles.; and (3) evaluate feasibility, acceptability, and appropriateness of the intervention in a pilot study of youth soccer leagues. The proposed aims will drive creation of a future community trial of the intervention, which will be the basis for R03 and R01 funding applications. In the process, Dr. Patel will become an expert in CEnR, qualitative methods, and implementation science, establishing him as one of the only orthopaedic surgeons conducting this type of research and a resource for others seeking to do the same.

Public health relevance
Although the frequency of athletic knee injuries in children has skyrocketed, delayed surgery due to multilevel factors can have lifelong consequences. This project will identify factors preventing timely surgery in high school athletes and design and test an intervention to reduce delayed treatment. In the future, the knowledge and intervention developed in this study will be adapted and disseminated broadly, resulting in better care for all youth athletes.